Mechanisms of sperm chromatin remodeling in vivo and in vitro

Abstract
Unlike oocytes (and all somatic cells), which package their DNA with histones, the DNA of mature sperm is
bound by protamines, a highly basic and rapidly evolving protein that is essential for compaction of the paternal
genome. This differential packaging of egg and sperm DNA traces back >500 million years, yet our
understanding of the principles of genome organization remains poorly understood. To examine this fundamental
yet poorly understood process we have developed novel genetic and biophysical tools to identify proteins
implicated in the histone-to-protamine exchange and to dissect the molecular mechanisms of chromatin
reorganization during spermiogenesis. In preliminary studies we developed epitope-tagged protamine 1 and 2
mice and relevant reagents such as specific antibodies. Immunoprecipitation followed by mass spectrometry has
identified multiple potential chromatin remodelers/chaperones, which we will functionally characterize in this
proposed study, both in vivo and in vitro. Since protamine packaging results in a super-condensed chromatin
state, which does not easily lend itself to mechanistic investigations in vivo, we have developed novel methods
to purify protamines from sperm to use in both in vitro DNA curtain assays and in vitro reconstitution assays of
the histone-to-protamine exchange process. The overall goal of this proposal is to apply our diverse suite of
genetic, molecular, and biophysical tools to gain mechanistic insights into normal sperm chromatin packaging,
which is essential for genome fidelity and reproductive fitness of the species.

Public health relevance
Public Health Relevance Infertility affects one in six couples worldwide, with men and women equally likely to have fertility problems. In men, known genetic factors account for ~10-15% of total infertility cases, whereas the remaining ~35-40% cases have an unknown etiology. Therefore, a comprehensive understanding of the genetic and molecular programs involved in proper germ cell development is required for development of better diagnostics and effective therapies.